Emerge, Leaders in Emerging Diseases Epidemiology Research Training

Program Director/Principal Investigator (Last, First, Middle): LESCANO, Andres G.
EMERGE, LEADERS IN EMERGING DISEASES EPIDEMIOLOGY RESEARCH TRAINING
2025-2029 RENEWAL PROPOSAL
Led by Andres G. (Willy) Lescano at Universidad Peruana Cayetano Heredia (UPCH) and partners
The renewal of this training grant application builds on the capacities previously established. An epidemiology
Masters and Doctorate have been created and continue to be independently of this training grant, providing
accessible educational opportunities for low and middle income country professionals. A large number of
Master’s and PhDs have graduated now, and together with Peruvian scientists trained abroad, many of them
serve as junior mentors of new graduate students in Peru, and have taken important leadership positions in
different research organizations. A strong Peruvian CDC lead by a former trainee of our program is making
important strides in partnering with different research groups and advancing the response capacities of the
country. Despite such valuable progress, the growth of future leaders in emerging diseases research is still
prevented by the limited funding opportunities for junior and mid-career scientists in LMICs such as Peru, and
limited experience of new investigators submitting grant applications. The next five years of this proposed
program will address this critical barrier with a multi-tier approach.
Our proposal, entitled “Emerge, Leaders in Emerging Diseases Epidemiology Research Training”, will generate
a model of a research environment micro-cosmos at UPCH working together with our broad network of
international partners. First, we will offer seed, short-term grants to conduct hypothesis-driven research
generating primary data via competitive requests for applications. Then, awardees will become fellows and will
be mentored to execute their research under US-Peru mentoring pairs, and produce peer reviewed
publications and future grant applications. Finally, research leadership training and mentoring will support
fellows to apply to local and international grant opportunities for junior scientists. Three emerging diseases
research methods courses directed to the Peruvian CDC staff will complement these efforts. Opportunities will
be open to all applications, but will specially target graduates of the Peru Epidemiology graduate programs,
former Fogarty-sponsored junior scientists and research-oriented Peruvian CDC junior staff. A fully-
implemented laboratory, with materials and methods for emerging diseases ecology research and a strong
partnership with the Peruvian CDC will provide the resources trainees need. Established partnerships in Peru
with the Peruvian CDC, AB PRISMA and Johns Hopkins, as well as world class research universities in the
US, as well as the ability to develop new collaborations will enable this strategy. More experienced fellows will
also receive leadership training and corresponding responsibilities, so one of them can potentially become the
PI or co-PI of the next training grant application, to bring further innovation and progress to the next stage of
this already successful program.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): LESCANO, Andres G. EMERGE, LEADERS IN EMERGING DISEASES EPIDEMIOLOGY RESEARCH TRAINING 2025-2029 RENEWAL PROPOSAL Led by Andres G. (Willy) Lescano at Universidad Peruana Cayetano Heredia (UPCH) and partners The COVID-19 pandemic ravaged Latin America and Peru specifically, demonstrating the importance of emerging diseases research and response capacities. Effective response to future outbreaks, epidemics and pandemics will require better-trained, experienced epidemiologists, in larger numbers. A partnership between the Peruvian CDC and world class academic institutions in Peru and the United States can prepare the next generation of emerging diseases specialists that an response to this challenge. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page